DEV OF AN ALGORYTHM FOR AREA INTEGRATION OF PEAKS FROM ELECTROSPRAY MASS SPECT

This algorythm was developed to assist in the quantitation of the incorportion of heavy-atom derivatives into proteins analyzed by ESI/MS.